A decisional intervention for older adults with acute myeloid leukemia and their caregivers

Therapeutic advances have allowed more adults aged ≥60 years with acute myeloid leukemia (AML) to receive
life-prolonging treatments. Nevertheless, the disease remains generally incurable with a two-year overall
survival of <20%. In contrast to other cancers, the onset of AML is often sudden, high-risk treatment decisions
must be made quickly, and survival is often compromised due to aging-related conditions (e.g., functional
impairments). In addition, we and others have demonstrated that up to 78% of older adults with AML and their
caregivers experience significant psychological distress. Distress is associated with poor quality of life,
increased healthcare utilization, and increased mortality. Shared decision making (SDM) can reduce patient
and caregiver distress and is essential to achieve goal-concordant care. Therefore, interventions to improve
distress and optimize SDM in older adults with AML and their caregivers are needed. Critical elements of SDM
include recognizing that a decision is needed, understanding options, and incorporating patient values into the
decision. To achieve SDM, patients must be knowledgeable about their disease, treatment options, and
prognosis, and their values must be incorporated into treatment decisions. In partnership with our patient and
caregiver advisory board, we have tested the feasibility of a multilevel decisional intervention (UR-GOAL) that
addresses critical elements of SDM for older adults with AML. UR-GOAL targets patients (caregivers) and
oncologists: 1) Patients view an educational video about AML diagnosis, treatment, and prognosis; complete
the BWS value clarification process; and review a summary report of their values with tailored question
prompts and resources; 2) Caregivers (if available) view the same educational video and receive the same
summary report as patients; 3) Oncologists review a summary report of the patient’s aging-related conditions,
perception of prognosis, and values. Patients (caregivers) and oncologists then meet to discuss aging-related
conditions, prognosis, and patient values during treatment decision making clinical visits. In our pilot studies,
we demonstrated that it was feasible to recruit this population. Preliminary findings showed that compared to
those receiving usual care, patient and caregiver randomized to UR-GOAL experienced lower distress at 1
month after a treatment decision was reached. We propose a multicenter randomized controlled trial to
evaluate the efficacy of UR-GOAL compared to an attention control for improving outcomes. We will recruit 300
older adults with newly diagnosed AML, their caregivers if available, and oncologists from four institutions. We
aim to assess the efficacy of UR-GOAL versus an attention control for: 1) reducing patient distress; and 2)
improving objective SDM, patient-perceived SDM, and decisional conflict. We will also assess other patient
(perception of prognosis, goal-concordant care), caregiver (distress, perception of prognosis), and healthcare
(emergency department visits and hospitalization in the last 30 days of life) outcomes. If successful, the
intervention has the potential to be extended to other cancer populations and diseases.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) The onset of acute myeloid leukemia (AML) is often sudden, high-risk treatment decisions must be made quickly, and survival is often compromised due to aging-related conditions, which lead to high distress among older adults with AML and their caregivers. Shared decision making can reduce patient and caregiver distress and is essential to achieve goal-concordant care. The proposed study will assess if a decisional intervention (UR-GOAL), developed in partnership with our advisory board, will improve patient, caregiver, and healthcare outcomes.